Improving weight loss outcomes of black women using a culturally relevant, stress management enhancement behavioral weight loss intervention

Black females have the highest prevalence of overweight and obesity than any other racial-gender
group in the United States with 4 out of 5 adult black females being overweight or obese. Furthermore, adult
black females tend to lose less weight than whites undergoing the same obesity intervention regardless of
treatment modality. Reasons for racial differences in weight loss outcomes are not fully understood, but
suggest opportunities to further optimize obesity treatment approaches to reduce disparities. Behavioral weight
loss (BWL) interventions offer one approach that has demonstrated effectiveness in promoting modest weight
loss among some participants with obesity, but black females tend to lose less weight than their white
counterparts in the same BWL program. We hypothesize that the higher prevalence of chronic psychological
stress, which has been linked to weight gain over time and poorer weight loss in BWL programs, reported by
black females contributes to the disproportionate prevalence of obesity and suboptimal weight loss observed
among this group. Thus, stress management offers a novel approach to weight management for black females.
Our preliminary work suggests that incorporating a strong stress management component into an evidence-
based BWL program can potentially lead to better outcomes than an evidence-based BWL program alone. For
this proposal, we will test the effectiveness of a 12-month culturally-targeted, stress management-enhanced
BWL intervention on weight loss and stress reduction in a fully powered randomized, controlled trial (n=340).
Adult black females with obesity will be randomized to either a stress-management enhanced BWL
intervention (BWL-Stress) or the same BWL intervention alone (BWL-alone). The specific aims are to 1)
conduct a randomized, controlled trial to determine the effects on body weight of BWL-Stress compared to
BWL-Alone among adult black females with obesity and elevated stress, 2) evaluate intervention effects on
psychological stress as measured by a validated survey instrument and a stress biomarker, and 3) using a
multiple mediation model, test whether the relationship between the intervention and weight change is
mediated by perceived stress, energy intake, and physical activity. The primary outcome is weight change at
month 6. Secondary outcomes will include changes in stress measures (e.g., survey measures, cortisol), blood
glucose, energy intake, and physical activity at month 6. We will also assess process measures (e.g, treatment
adherence, treatment burden). We will also evaluate each outcome at month 12. This novel approach for
enhancing an evidence-based BWL program with culturally-targeted stress management strategies for black
females targets an understudied contributor to weight management among a population at high risk for obesity
and obesity-related chronic diseases (e.g. type 2 diabetes, cancer). This study will also elucidate behavioral
mechanisms linking our novel intervention to study outcomes. If proven effective, it would have significant
clinical and public health implications for weight management among black females.

Public health relevance
PUBLIC HEALTH RELEVANCE: Obesity is a significant public health concern that is disproportionately represented among adult black females. Current obesity treatment strategies among this population produce suboptimal weight loss outcomes. This project will determine whether addressing stress management among a group of adult black females with obesity and elevated stress will lead to greater weight loss than standard behavioral weight loss programs.